Postdoctoral Research Training in Alzheimer's Disease and Related Neurodegenerative Disorders

This is a proposal to renew an advanced postdoctoral training program focused on Alzheimer’s disease and related neurodegenerative disorders at NYU Grossman School of Medicine. There is a critical need to train early career scientists who will investigate Alzheimer’s disease and related neurodegenerative disorders, develop new interventions, and translate these findings from bench to bedside and from bedside to community. The program will continue to be housed in the Center for Cognitive Neurology, an extra-departmental, multidisciplinary program designed to foster collaborative research, with 37 faculty members serving as mentors. The goal of the program is to endow trainees with diverse scientific backgrounds with the necessary skills, multidisciplinary approaches, and rigorous methodologies to advance the field of Alzheimer’s disease and related neurodegenerative disorders. This renewal application expands our current training program by appointing exceptional cognitive neurology clinician-scientist researchers. We will build on our previous training program by appointing three postdoctoral trainees and one cognitive neurology fellow from a well-qualified pool of MD, MD/PhD, and PhD applicants. As per the NIH recommendation for postdoctoral research training, the trainees will be appointed for two years and will continue to receive mentoring and career development support in subsequent years. The program's goals to train these fellows will be accomplished through a tailored curriculum that includes training in rigorous research techniques and quantitative analysis, enhanced mentorship, didactics in foundational concepts, honing science communication skills, and career planning. This training program enables postdoctoral fellows to prepare for the intensely collaborative and interdisciplinary nature of modern research by providing: (a) high-quality scientific training in the area of Alzheimer’s disease and related neurodegenerative disorders, clinical approaches, statistical analyses, and rigorous experimental design; (b) enhanced mentoring that aids trainees’ progress toward future careers in science, and (c) training in the professional skills that are necessary for success in academic research, including critical reading, grant writing, oral presentation, leadership, management, and networking. The training of the next generation of research and clinician scientists with expertise in Alzheimer’s disease and related neurodegenerative disorders is, and will remain, a public health priority in the United States for many years to come. Our collaborative T32 program supports these early scientists as they launch their independent and successful careers in this critical field.

Public health relevance
Project Narrative This renewal application proposes training postdoctoral candidates and cognitive neurology fellows researching Brain Aging and Neurodegenerative Diseases at NYU Langone Health (NYULH). There is a critical need to train the next generation of MD and PhD researchers to investigate disorders of brain aging, develop new therapeutics and interventions, and translate these findings from bench to bedside to the community. This training program is housed in the Center for Cognitive Neurology, a school-wide, extradepartmental, multidisciplinary program designed to foster collaborative, translational research at NYULH and will train the next generation of research and clinician scientists in rigorous methodologies and innovative approaches to advance the field of brain aging and neurodegeneration